A Proactive Missense Variant Atlas for the Autoimmune Regulator

Project Summary/Abstract
Pathogenic variants of the Autoimmune Regulator (AIRE) gene cause the primary immunodeficiency disease
Autoimmune Polyendocrine Syndrome Type 1 (APS-1; also called Autoimmune Polyendocrinopathy with
Candidiasis and Ectodermal Dystrophy), which manifests as symptoms including chronic mucocutaneous
candidiasis, hypoparathyroidism, and Addison’s disease among other autoimmune symptoms. AIRE prevents
autoimmunity by increasing the expression of tissue-specific genes in the niche of developing T cells, allowing
for the elimination of emerging self-reactive T-cells before they can mature. Sequencing of AIRE is an
increasingly common tool to diagnose APS-1, and earlier diagnosis can benefit patients. However, diagnosis is
limited by the fact that two thirds of variants are missense, and that more than half of the missense variants
found are “of unknown significance”. Testing the function of variants in cultured cells can provide strong
evidence for more informative variant classification, but these tests are carried out reactively, often months or
years after a new variant is first observed in a patient. A proactive solution to this problem is to efficiently
assess the function of all possible missense variants to generate a sequence-function map. Such maps can
provide immediate and accurate evidence to diagnose disease, even for never-before-seen variants. We have
developed and validated one scalable assay for testing AIRE missense variants, using human cells with a
fluorescent reporter of insulin promoter activity, and are exploring other scalable assays. We will:
1) Generate a sequence-function map to enable more accurate clinical interpretation of AIRE missense
variants and;
2) Validate and characterize the AIRE sequence-function map.
A sequence-function map of AIRE will provide key proactive evidence for rapid and definitive genetic diagnosis
of APS-1, and ultimately more positive patient outcomes.

Public health relevance
Narrative With growing use of patient sequencing to diagnose Autoimmune Polyendocrine Syndrome Type 1 (APS-1), a rare disease caused by damaging variants in the autoimmune regulator gene (AIRE), the need to better interpret pathogenicity of rare sequence variants has also grown. Functional assays are one of the strongest forms of evidence for variant interpretation according to current guidelines, but such testing is generally reactive, as variants are first seen in the clinic, and results often arrive months or years after. Instead, we propose to proactively evaluate every missense variant of AIRE, yielding a proactive sequence-function map to enable more accurate clinical interpretation of AIRE missense variants.